eMOA: A Multi-Omic Service for Mechanism of Action Determination in Drug Screening

Summary
The pathway to a successful drug development program is getting more challenging and expensive every year.
Currently, bringing a single therapeutic compound to market starts in early discovery by the broad screening of
tens of thousands of molecules and is usually followed by a series of precise assays to reduce the number of
compounds to a handful of candidates. For these candidates to enter clinical trials, regulatory agencies are now
demanding that the molecular mechanism of action is well understood. Traditionally, that meant years of basic
research using low throughput and complicated assays within a research program. The combination of the
secondary screening assays together with the basic research needed to understand the mechanism of action
can not only be very costly, but also create delays for these new therapeutic agents to reach patients. Currently,
some of the secondary screens measure gene expression levels using transcriptomics, shotgun proteomics as
well as a combination of other omics approaches. Recently, regulation of translation has emerged as a new
mechanism by which drugs can act on cellular functions. For example, the mTOR pathway that regulates cell
proliferation, apoptosis, autophagy, and other cellular processes, participates in multiple cell-signaling pathways
directly influencing translation of specific mRNAs. Several compounds inhibiting the mTOR pathway have been
identified, including Torin 1 and Sapanisertib, and their mechanism of action have been shown to be through
direct inhibition of translation. Eclipsebio’s eRibo Count will be modified for higher throughput screening of small
molecules and used to commercially deploy a secondary drug screen platform, called eMOA, that will use both
transcriptomics and translatomics to rapidly narrow down the number of candidate molecules of interest. Phase
I will focus on screening for a monoclonal antibody that will reduce signal to noise as well as identify basic
parameters, such as sequencing depth and library complexity, that will allow for successful identification of
candidate compounds with precise mechanism of action information. Phase II will incorporate the Phase I
development and findings to allow drug screening via the eMOA platform to be performed in a 96-well plate,
allowing for mid throughput screening. In addition, eMOA will be used to screen a library of ~1,500 distinct,
clinically relevant compounds with detailed mechanism of action. This will be used to train a machine learning
model that will enable classification of unknown compounds for rapid identification of their mechanism of action.
This drug screening platform will be further developed to include a rich user interface enabling customers to
better understand their new therapeutics. Eclipsebio will provide the eMOA platform as a white-glove service for
biotech and pharma to shorten their research cycle, providing better compounds to patients in clinical trials.

Public health relevance
Narrative The traditional path to the successful development of new therapeutic compounds consists of a timeline spanning years to decades and budgets estimated into the billions of dollars; it typically begins with the screening of tens of thousands of small molecules, which are then narrowed down to a few tens of molecules before ever starting the clinical trial phases. Recently, regulatory agencies have been demanding a deeper understanding of the mechanism of action (MOA) before compounds are allowed to enter clinical trials. In this SBIR application, we are proposing to develop a secondary drug screening platform, called eMOA™, that will enable faster and more cost-effective drug development by leveraging both transcriptomics, translatomics, and a database of small molecules with known MOA to power a machine learning model to assign MOA to newly screened compounds.